Sub-Voxel Tissue Characterization With In-Vivo MRI

PROJECT SUMMARY Magnetic resonance imaging (MRI) is a uniquely informative soft tissue imaging modality with contrast that is sensitive to a myriad of physical, chemical, and functional characteristics of tissue but often lacks specificity. On the spatial scale relevant to water proton (1H) nuclear magnetic resonance (NMR), tissues are heterogeneous and, consequently, exhibit an NMR signal that is the complex summation of spatially varying characteristics. Most MRI protocols provide contrast between tissues that can be resolved spatially, but yield little or no quantitative information about the variation in NMR signal that exists on a smaller scale, that is, the sub-voxel scale. This quantitative sub-voxel information is alluring because it provides specificity to tissue micro-anatomy. Development of quantitative sub-voxel MRI tissue characterization requires coordinated advancement on two fronts: 1) quantitative models that relate relevant micro-anatomical characteristics to 1H NMR signal characteristics, and 2) practical and effective quantitative MRI methods that can translate these the use of sub-voxel tissue models to widespread utility for researchers and clinicians. The proposed studies address both modeling and method development with the aim to develop practical and quantitative imaging biomarkers for micro-anatomical characteristics of white matter and skeletal muscle, including 1) myelin volume fraction and myelin thickness in normal, developing, and abnormally developing white matter, and 2) myofiber volume fraction and size, in the presence of inflammation and fibrosis. Such biomarkers have the potential to impact research and clinical diagnostics by providing quantitative and specific measures to track changes in disorders associated with abnormal white matter development, such as Schizophrenia and Autism, as well muscle injuries and diseases such as Muscular Dystrophy.

Public health relevance
Project Narrative MRI is a widespread diagnostic imaging modality capable of relatively non-invasive visualization of soft tissue. The contrast in MRI results from many complex interactions of water molecules in the body with each other and the physical and chemical characteristics of their local environments. This research program aims to better relate MRI contrast to specific micro-anatomical characteristics in neural tissue and skeletal muscle. This work has broad potential impact the diagnostic and prognostic capabilities of MRI for a wide array of diseases and injuries. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The overarching aim of this project is to develop practical and quantitative imaging biomarkers for micro- anatomical characteristics of white matter and skeletal muscle, including 1) myelin volume fraction and myelin thickness in normal, developing, and injured white matter, and 2) myofiber volume fraction and size, in the presence of inflammation and fibrosis. Such biomarkers have the potential to impact research and clinical diagnostics by providing quantitative and specific measures to track changes in disorders associated with abnormal white matter development, such as Schizophrenia and Autism, as well muscle injuries and diseases such as Muscular Dystrophy. A fundamental tenant of this research program is that developing MRI methods with greater micro- anatomical specificity first requires detailed quantitative studies that explore and reveal the relationship between tissue micro-anatomy in a wide range of conditions and the 1H NMR signal at the most basic level possible. A key hypothesis that underlies this tenant is that some micro-anatomical characteristics which are too complex to be captured by simple models are nonetheless important to image contrast in clinically relevant MRI protocols. A second and more recently established tenant of this research program is that it is alo important to devise and validate practical translatable methods to quantitatively probe sub-voxel tissue models. This tenant dictates that we must look beyond methods that provide the highest accuracy and most comprehensive evaluation of tissue (which are used to build the models) to methods that accept a reasonable degree of inaccuracy in exchange for rapid, multi-slice acquisition based on widely available or readily implemented MRI pulse sequences. In the last year of our funding (this project was renewed in 2009 for two years with ARRA funds), we have developed experimental and computational tools for sub-voxel tissue studies of water diffusion and NMR relaxation; we have performed in vivo and ex vivo studies of the peripheral and central nervous systems, and in vivo studies of skeletal muscle; and we have laid foundation for the development and/or refinement of methods that can characterize sub-voxel tissue components using practical multi-slice/3D MRI protocols. This work has resulted in 17 new papers (plus 6 more in review or preparation) and substantial preliminary data since our last proposal, and provides a robust platform for the further tissue characterization and method development proposed herein. In particular, through developing and/or implementing a wide variety of MRI methods, on a variety of neural and muscle tissue models, along with quantitative histology and histology- defined numerical simulations of NMR relaxation, diffusion and magnetization transfer, we will pursue the following aims: 1. develop quantitative imaging biomarkers that are specific for micro-anatomical characteristics of white matter (myelin volume fraction and myelin thickness, in particular). We propose to study normal, developing, and abnormally-developing rat cerebral and spinal white matter with a variety of MRI experiments, quantitative histology, and histology-defined computer simulations in order to a) establish quantitative empirical relationships between numerous MRI and histological measures, and b) seek a parsimonious ensemble of tissue model parameters that best explain the wide variety of histological and MRI observations. 2. develop quantitative imaging biomarkers that are specific for micro-anatomical characteristics of injured or diseased skeletal muscle (myofiber volume fraction and myofiber diameter, in particular) We propose to study ischemia-reperfusion injury and in rat and a mouse model of Duchene Muscular Dystrophy using our recently developed MRI method of characterizing a two-pool model of skeletal muscle water (T1, T2, diffusion, and inter-compartmental exchange rates), along with quantitative histology and histology- defined simulations to characterize the relationships between numerous quantitative MRI measures and quantitative tissue characteristics, such as myofiber size and myofiber volume fraction. 3. develop, optimize, validate and compare practical multi-slice (or 3D) methods for sub-voxel tissue characterization. We will develop upon novel or recent methods for quantitatively studying compartmental models of 1H NMR in white matter and muscle. All methods will be critically analyzed and optimized to minimize variance of estimated quantitative biomarkers, tested against gold standard methods in phantoms and select tissues from Aims 1 and 2, and validated by comparison to quantitative histology. Ultimately, Aims 1, 2, and 3 will be undertaken in parallel and with coordinated effort to establish comprehensive models of tissue that are consistent with a wide range of tissue conditions and to develop practical, translatable imaging biomarkers for white matter and skeletal muscle.